Establishing Mechanisms of Benefit to Reinforce the Alzheimer's Care Experience AD/ADRD Roybal Center: EMBRACE

Project Summary/Abstract-Behavioral Intervention Development Core
The proposed Establishing Mechanisms of Benefit to Reinforce the Alzheimer’s Care Experience
AD/ADRD Roybal Center (EMBRACE) Behavioral Intervention Development Core (BIDC) will assist
Investigators in the conduct of mechanism-driven, home and community dementia care intervention trials
across Stages 0-V of the NIH Stage Model. Investigators will have access to pre- and post-award consultation
to ensure that EMBRACE-supported trials are positioned to progress to subsequent stages of the NIH Stage
Model. The BIDC will also develop and disseminate resources needed for EMBRACE Investigators and the
field to advance their science of mechanism-based dementia care research. The Specific Aims of the BIDC are
to: 1) Support EMBRACE Investigators and their trials so that they can effectively identify, measure, and test
mechanisms of action in their tailored, dementia care interventions in home and community settings; 2)
Implement a robust consultation and engagement model; and 3) Develop and disseminate the intellectual and
material resources needed for Investigators to conduct home and community intervention trials. In
collaboration with the Administrative Core, the BIDC will provide the critical research infrastructure necessary
to support EMBRACE Investigators and will stimulate broader dissemination to advance the science of
mechanism-based dementia care research in home and community settings.